PROJECT 4: Targeting Methionine Adenosyltransferases in Liver Metastasis

PROJECT 4: Targeting Methionine Adenosyltransferases in Liver Metastasis
ABSTRACT
A key central hypothesis for this Program is that the normal liver has defense mechanisms to suppress metastatic
growth. Project 4 is focused on the role of methionine adenosyltransferase (MAT) proteins, with MAT1A
defending against liver metastasis, while MAT2A and MAT2B break down this defense. MAT catalyzes the
formation of S-adenosylmethionine (SAMe), the methyl donor. The MAT1A and MAT2A genes encode MAT α1
and α2 catalytic subunits, respectively; a third gene, MAT2B, encodes the β subunit that regulates the MAT2A-
encoded enzyme. MAT1A, expressed in normal liver, is downregulated in liver diseases, whereas MAT2A and
MAT2B, expressed in non-hepatic tissues, are overexpressed in multiple human cancers. Preliminary data show
that Mat1a knockout (KO) mice are highly sensitized to develop liver metastasis and release extracellular
vesicles that contain oncoproteins; whereas MAT2A/MAT2B have a reciprocal inhibition interplay with
metastasis-inhibiting tumor suppressor miRNAs miR-34a and miR-34b, but have a positive feed-forward loop
with the metastasis-promoting oncogene Forkhead box M1 (FOXM1). In contrast, MAT1A and FOXM1 negatively
regulate each other. Project 4 examines the effect of three molecules that target these interplays to inhibit liver
metastasis: SAMe; its metabolite methylthioadenosine (MTA); and the FOXM1 inhibitor FDI-6. This project tests
the hypothesis that high MAT2A/2B expression in cancer cells enhances liver metastasis by lowering hepatic
MAT1A, and that SAMe, MTA, and FDI-6 inhibit liver metastasis in part by targeting MAT proteins. Importantly,
human livers with metastatic cancers have lower MAT1A expression and the GEO database shows metastatic
colon, pancreatic and prostate cancers have higher MAT2A/2B expression. Core B will provide human
specimens and animal models to examine these MAT proteins in liver metastases from colon, pancreas, and
prostate cancers over three specific aims: Aim 1. Examine the role of hepatic MAT1A expression in liver
metastasis. This aim will test the hypothesis that loss of MAT1A alters extracellular vesicle content released by
the liver to enhance metastatic growth. Aim 2. Determine if MAT proteins expressed by the cancer influence
liver metastasis. This aim will elucidate the mechanisms responsible for MAT2A/MAT2B-mediated regulation
of miR-34a/b and FOXM1, and examine whether higher MAT2A/2B expression in cancer cells enhance liver
metastasis. Aim 3. Examine mechanisms and therapeutic potential of SAMe, MTA, and FDI-6 in liver
metastasis. This aim will assess the effects of these three molecules (individually and combined) on cancer cell
migration and invasion in vitro. The best therapy will be verified in vivo using mouse models and orthotopic
patient-derived xenografts established using tissues from patients with liver metastasis. Project 4 synergizes
with: Project 1, as endoglin/BMP signaling activates FOXM1, Project 2, as MAT1A expression falls in fatty liver
and Mat1a KO livers have higher hyaluronic acid; and Project 3, as Metavert lowers MAT2A expression.
Successful completion will define clearly the role of MAT proteins in liver metastasis.

Public health relevance
PROJECT NARRATIVE Methionine adenosyltransferase 1A (MAT1A) is expressed in normal liver and its expression falls in patients with fatty liver disease, whereas MAT2A and MAT2B are expressed in non-liver tissues and are induced in multiple human cancers. This project examines the hypothesis that while hepatic MAT1A protects the liver against cancer metastasis, elevated MAT2A and MAT2B expression in cancer cells lowers this defense. Successful completion of this project will reveal novel mechanistic insights that may help us to understand the complex interactions between the homing site (i.e., liver) and infiltrating cancer cells, which could lead to new therapies to prevent metastasis across all types of tumor.